Core C: Data Management and Statistical Core

Abstract:

ABSTRACT: DATA MANAGEMENT AND STATISTICAL CORE The Data Management and Statistical (DMS) Core (Core C) supports the University of Kansas Alzheimer's Disease Research Center (KU ADRC). DMS Core faculty and staff have the training and experience to support the research needs of investigators that utilize KU ADRC resources. The central focus of this core is managing and maintaining the entire spectrum of study-related information for the Clinical Cohort that is collected across the cores and research projects. To support this objective a REDCap web-based data capture platform is utilized. Data are prepared for extraction by investigators and NACC, as well as provide statistical, bioinformatics, and data science expertise for research using the center. To support AD research the DMS Core has the following specific aims. Aim 1: Integrate, develop, and disseminate data and information management systems consistent with the evolving needs of AD research Aim 1a: Provide platforms for data capture, integration, and visualization for core-to-core integration Aim 1b: Efficiently integrate, organize, curate, and disseminate research data Aim 2: Enhance the quality of AD and aging research by providing investigators with statistical, `omics, and data science expertise Aim 2a: Support study design, oversight, and data analyses Aim 2b: Collaborate and consult in the preparation of study presentations and publications Aim 2c: Develop novel quantitative and data science methodologies to improve inference The DMS Core remains highly integrated across the cores. Data management, data extracts, and statistical support are provided, and the DMS Core has key roles as liaisons for core-to-core and core-to-research project interactions. The Core also supports the development and applications of tools and expertise for biostatistics, bioinformatics, and data science needs of AD research.